Informing Drug Synergy: Investigating Mycobacterial Membrane Protein Structure and Function

Abstract
The multi-layered cell envelope of Mycobacterium tuberculosis (Mtb) is a critical barrier to antibiotics and an
important target for drug development. Disrupting its assembly increases bacterial susceptibility to existing
antibiotics, creating opportunities for synergistic therapies. This proposal aims to elucidate the molecular
mechanisms underlying envelope assembly, focusing on key membrane proteins, whose structures we
have determined. Aim 1 investigates the cytoplasmic synthesis and transport of mycolic acids, essential
fatty acids in the mycomembrane, by investigating the spatio-temporal localization of Pks13 and its
interaction with fatty acid synthases. Aim 2 defines the physiological role of the essential efflux pump EfpA,
hypothesizing it functions as a lipid transporter, and explores its inhibition as a therapeutic strategy. Aim 3
characterizes proteins that coordinate mycomembrane biosynthesis, particularly PgfA, to understand how
this process is regulated for balanced cell growth. These studies will provide crucial insights into M.
tuberculosis envelope construction, paving the way for novel, synergistic TB therapies that enhance the
efficacy of existing treatments.

Public health relevance
Narrative The multi-layered cell envelope in mycobacterium tuberculosis serves as both a powerful barrier to many antibiotics and a rich source of potential drug targets that coordinate the assembly of the cell wall. Here, we leverage innovations in light and electron microscopy, cryo electron tomography and the expertise of two labs in protein structural and cellular biology, to determine the function of three critical pathways that are essential to cell wall synthesis. Our vision is that this knowledge will establish the principle of structure- based drug development against these targets, and so be synergistic with current treatment for tuberculosis.